Advancing Genomic Interpretation for Chromatin Remodeling Enzymes

PROJECT SUMMARY/ABSTRACT
The functional interpretation of human genetic variation needs to catch up to our ability to catalog the DNA
sequences of individuals. Better tools are required to interpret mutations’ effects, improving our ability to
diagnose and treat diseases. Our goal is to accurately predict which mutations cause human disease by
developing tools for three-dimensional and context-dependent interpretation of genetic information. We focus on
genes that regulate the genome, known as epigenetic enzymes. We will specifically study the chromatin
remodeler, SMARCA4, which enables the genome to be used in the right amount at the right time. SMARCA4 is
critical to study because 1) it is required for normal physiology and development, 2) germline mutations define
rare and undiagnosed diseases that affect people of all ethnicities and genetic ancestries, 3) somatic mutations
underly cancer development from many body tissues, making new findings of high biomedical value. Additionally,
epigenetic regulators are often associated with more than one medical condition. This data conveys epigenetic
enzymes' powerful and multi-faceted functions and their ability to orchestrate many different physiologic changes
that can differ across individuals. Further, the distinct physiological contexts that SMARCA4 acts within will vary
across body tissues and over time. SMARCA4 is the catalytic unit within the BAF complex, which also exists as
different sub-complexes, necessitating the study of each. This concordance affords a pivotal opportunity to
develop new procedures for helping more patients with diverse congenital and somatic diseases and better
understand this chromatin remodeler's normal functioning. Our central premise is that SMARCA4 mutations alter
specific features of the encoded 3D protein in quantifiable ways using novel computational tools that generate
mutation-specific functional calculations. This is important since current guidelines for genetic diagnosis are
primarily based on linear sequences rather than 3D features of gene products, and these guidelines fail to
capture many pathogenic mutations that likely cause diseases. More importantly, our methodology applies to all
diseases, independent of the affected cell or organ, and performs with the same high accuracy for cancers and
non-cancer diseases. Our proposal will generate specific deliverables that fill crucial knowledge gaps for
advancing data science for genomics. Current data science methods in genomics are primarily based on
sequence-based evolutionary conservation and population-level empirical observations. Thus, existing methods
fail to reveal genetic differences specific to individuals and fail to provide actionable mechanistic information.
Using mutation-specific structural, dynamic, and systems-level annotations, our work offers a more powerful
interpretive toolset across diverse clinical and research domains. We will benchmark our approach against
current tools, validate via clinical cases, and bring information of mechanistic value that can be tested
experimentally. Finally, we will develop a scalable process that can, through future work, be applied to additional
epigenetic enzymes.

Public health relevance
PROJECT NARRATIVE We develop the means to bring powerful computational tools from basic sciences to interpret the effects of genetic changes in a gene named SMARCA4. As genetic data are increasingly available, there is a great need for better tools to interpret their impact and enable more people to benefit from their genomic data. Our study is an innovative approach for its novel combination of computational tools that will provide a more comprehensive and context-aware interpretation than any existing approach, using large amounts of experimental data and showing how to enter the next generation of genomic data interpretation.